The Center for Open Bioimage Analysis

Project Summary
The R24 funded Center for Open Bioimage Analysis will serve the cell biology community’s growing need
for sophisticated software for light microscopy image analysis. Quantitative image analysis has become an
indispensable tool for biologists using microscopy throughout basic biological and biomedical research.
Quantifying images is now a critical, widespread need as imaging experiments continue to grow in scale,
size, dimensionality, scope, modality, and complexity. Many biologists are missing out on the quantitative
bioimaging revolution due to lack of effective algorithms and/or usable software for their needs, or lack of
access to training. The Center brings together the Cimini laboratory at the Broad Institute and the Eliceiri
laboratory at the University of Wisconsin-Madison, and in doing so unifies the two most popular open source
bioimage analysis projects, ImageJ (including ImageJ2 and FIJI) and CellProfiler. Through the collaborative
development and dissemination of open-source image analysis software, as well as training events and
resources, the Center will empower thousands of researchers to apply advanced analytics in innovative ways
to address new experimental areas.
Building on the team’s expertise developing algorithms and user-friendly software for use in biology under
real-world conditions, the Center will focus on three specific aims: 1) Maintain state-of-the-art access to
evolving image analysis methods in established user-friendly tools such as ImageJ, Fiji, CellProfiler, and Piximi
2) Improve access to and accessibility within open-source image analysis tools, embracing additional
deployment approaches and 3) Improve interoperability of open-source image analysis tools and methods,
including cross-language interoperability across Java, Python, and JavaScript
This work will not occur in isolation; rather, the Center will nucleate a larger community working on these
three areas and serve as a catalyst and organizing force to create software and resources shared by all. Our
teams are accustomed to working deeply and iteratively on problems side by side and with frequent feedback
from biologists. Continuing the teams’ track record with ImageJ and CellProfiler, two mature open source
bioimage analysis software projects critical to the work of biologists worldwide, the Center will also assist and
train biologists in applying the latest computational techniques to important biological problems involving
images.
In short, the need for robust, accurate, and readily usable software is more urgent than ever. The Center for
Open Bioimage Analysis will serve as a hub for pioneering new computational strategies for diverse biological
problems, translating them into user-friendly software, further developing ImageJ and CellProfiler, and training
the biological community to apply advanced software to important and diverse problems in biology.

Public health relevance
Project Narrative Biologists studying a huge variety of diseases and basic biological processes need software to measure cells, tissues, and organisms in microscopy images. The proposed R24 Center for Open Bioimage Analysis will catalyze the scientific community, creating resources, maintaining free software, and offering training that allow biologists to analyze images using deep learning and other image processing algorithms, offering improved accuracy, convenience, and reproducibility.